TRD 3 - Enabling Technologies for Intraprocedural Guidance

ABSTRACT
Recent advances in personalized medicine have been accompanied by increasing recognition
of image-guided interventions. Two critical needs have to be addressed before image-guided
intervention plays a key role in precision medicine – the successful application of imaging as a
predictive biomarker of therapeutic efficacy and the development of devices to identify, sample, and
monitor target tissues. The goal is to develop a set of intraoperative devices through synergistic
interactions of technical and biomedical expertise and deliver prototypic software tools/devices
enabled by 3D Slicer. Aim 1 Intraoperative needle guidance for prostate biopsy and ablation
We will
create, test, and validate image-guidance software to address needle deflection and provide an
optimal insertion path for in-bore MRI-guided biopsy and ablation of prostate cancer. This aim will
deliver a complete set of tools namely-a transperineal template with fine grid pattern and guidance
software that takes into account needle deflection. Aim 2. Development of an intraoperative
visualization and navigation for lung surgery. We will develop an augmented reality (AR)-guided
navigation system for laparoscopic lung surgery to be integrated with novel computer vision and
machine learning algorithms to compensate for lung deformation. We will also develop machine-
learning based feature descriptors to accurately track anatomical features from stereo laparoscopic
images. Aim 3: Technical development of an implantable microdevice with integrated retrieval
mechanism. We will develop new implantable microdevice (IMD) prototypes that have integrated
retrievability for difficult to access tissues such as the brain-within a focal tumor -each IMD contains
up to 20 individual wells for installation of drugs. We will use image guidance for optimal placement -
in the tumor, to allow focal and controlled release of these drugs and then image guided device
retrieval (removal). Once the image guided retrieval the IMD is removed with a “cuff” or rim of tissue,
this will undergo pathological analysis to discover if an adequate amount of tissue is present and then
analyzes of local tissue/tumor response. Collaborating projects will be benefitted by incorporating
novel and clinically tested devices and associated software made possible in the TRD 3.